Novel, low corrosion, bio-compatible disinfectant with biofilm and residual efficacy

PROJECT SUMMARY
In the US, about 1.7 million Healthcare-Associated Infections (HAls) occur in hospitals each year, resulting in
99,000 deaths and an estimated $35 billion in healthcare costs. According to previous reports, as much as one
third of HAI cases can be attributed to environmental surfaces. Biofilms are an active topic and have been
identified as contributing to as much as 70% of infections. Hospital drains, and the biofilms they house are also
an important concern. Clostridium difficile is also an ongoing concern, but the most recent pathogen of concern
is Candida auris which can contaminate surfaces surrounding colonized patients in as little as 4 hours after
disinfection and rebound quickly from disinfectant use, again in as little as 4 hours.
Halomine dba AvantGuard has developed a novel chloramine-based disinfectant modeling our immune system’s
use of taurine chloramine to kill pathogens. Our compound, developed during our Phase II, is a polymer which
is a combination of an N-halamine containing monomer, called Avantamine, and other monomers that improve
solubility. We have demonstrated Avantamine is similar in efficacy to other chlorinated disinfectants, can make
biofilm efficacy claims using EPA protocols against bacteria and C. auris, can pass EPA residual disinfectant
testing at concentrations that show no skin irritation and no corrosion of metals and plastics. Avantamine also
should not generate resistance.
This Phase IIB project will finish development by finishing efficacy evaluation and testing, optimizing the product
and formulating with additives as necessary, finalizing the product package and obtaining third party data on
chemical characterization, toxicology and efficacy.

Public health relevance
PROJECT NARRATIVE Halomine, dba AvantGuard, is developing a novel disinfecting compound that has the efficacy of chlorine-based disinfectants, but is non-corrosive at high concentrations, safe in contact with skin, and has residual disinfectant capabilities. The safety profile for skin and surfaces enables high concentrations to be used regularly and allow for claims against biofilms for a variety of organisms. The new compound should make an impact in healthcare settings where biofilms are currently thought to be responsible for 70% of healthcare acquired infections.